Integrative Program in Complex Biological System (ipCBS)

PROJECT SUMMARY / ABSTRACT
This is an application for renewal of the Integrative Program in Complex Biological Systems (ipCBS), a
graduate training program providing a specialization for students that are members of the Biophysics and
Bioinformatics group. The ipCBS is a comprehensive interdisciplinary program specifically designed around the
engineering of complex biological systems (“synthetic biology”). At a fundamental level, this program seeks to
solve the sociological and linguistic problems associated with training scientists and engineers to be
simultaneously conversant in the multiple languages of biology, mathematics, physics, and engineering. A key
feature of the ipCBS is the fact that UCSF is medical campus, so that our students can exploit opportunities to
explore and engineer biological complexity in the context of health and disease. Over the past grant period, the
ipCBS has continued to develop and evolve the curriculum, especially in the area of hands-on project based,
experiential learning. As a result, a purpose-built Graduate Teaching Laboratory was constructed as a direct
outcome of this training program, and projects-based courses conducted in the spirit of Cold Spring Harbor /
Woods Hole, have become a keystone of the graduate first year experience.
The key points of the ipCBS are as follows:
• Long term objective: To provide critical training necessary to lead innovation in a synthetic and systems
biology research environment driven by team-based interdisciplinary approaches to biomedical science and
human health and dominated by large-scale and high complexity data characteristic of precision medicine.
• Approach: The ipCBS holds four core principles as the basis for graduate training. 1) Focus on the “design
principles” of biological organization, from the molecular to the cellular level. 2) Focus on the challenge of
engineering synthetic circuitry within complex systems from an interdisciplinary team-based perspective. 3)
Focus on breaking down the language/sociology barrier. 4) Focus on mentoring.

Public health relevance
PROJECT NARRATIVE The UCSF integrative program in Complex Biological Systems seeks to educate diverse students to become the next generation of quantitative biology researchers and engineers, empowering them to tackle the most pressing issues facing medicine, biology, and public health, through an interdisciplinary combination of engineering, biology, informatics, physics, and computer science.